Project 2: STAT3 as a trigger for T1D

Project Summary/Abstract
Monogenic diseases that have a close association with the development of type 1 diabetes have been
informative for unraveling critical pathways that keep this disease in check. Examples of success using this
approach include the study of AIRE and FOXP3 which have been informative for identifying pathways in the
thymus and T regulatory cells that keep type 1 diabetes in check. Here, we will leverage the recent knowledge
that gain of function mutations (GOF) in STAT3 are tightly associated with the development of type 1 diabetes
by developing a robust animal model of the syndrome.
Our specific aims are:
Aim 1: Model the effects of STAT3 GOF in a novel mouse model of autoimmune diabetes
(NOD.STAT3K392R/+)
Aim 2: Identify and characterize key immune cell populations that are defective in the NOD.STAT3K392R/+
model and in patients with similar STAT3 GOF mutations
Aim 3: Identify how central tolerance is potentially altered in STAT3 GOF models
These studies will be performed in close collaboration with PPG projects 1 (Cooper) and 3 (Marson) and will
help improve our understanding of how the immune tolerance is controlled by STAT3 and how alterations in
this molecule can provoke type 1 daibetes.